Ambulatory Methods for Measuring Cognitive Change

Project Summary
The primary objectives of this Core are the broad support for use of the M2C2 mobile tests and associated
APIs and research planning tools and for the dissemination of these materials to build a community of
researchers for long-term sustainability and continued innovation. The Dissemination function of this core is to
share data, software (including source code), testing procedures, and relevant documentation with the broader
research community. The Extension function of this core is to establish procedures and a pipeline for additional
test development and promote uptake of M2C2 tools by the research community for use in new and existing
studies, clinical trials, and health care settings. To promote uptake of M2C2 tools, we will develop
interoperability with popular mobile and survey data collection software. In this Core, we describe processes
for actively encouraging uptake of the test infrastructure and support of researchers outside of our immediate
team to contribute new measures for inclusion in the M2C2 infrastructure following processes established by
the Project. This Core will ensure access to study data and metadata to support reproducible and replication
research under FAIR data principles and encourage external researchers to contribute data to the open
science M2C2 platform to accelerate test development, optimal design, and data analytics. The specific aims
of this Core are: (Aim 1) To implement a comprehensive plan to promote dissemination, uptake, and ongoing
development of the M2C2 resource by the research community; (Aim 2) To support rapid development,
validation and deployment of novel cognitive measures with the research community and sustain innovations in
mobile assessment methodology; and (Aim 3) To support widespread uptake of M2C2 assessment tools, we
will provide public APIs to allow integration of cognitive testing with other mobile and survey data collection
software (e.g., REDCap).
The long-term impact of this overall project relies on the uptake of mobile assessments in a broad
range of research designs and clinical contexts. This Core will provide resources and protocol for
dissemination, support, and extension of an open, flexible, and sustainable research infrastructure. The
significance of this Core is that it will support the broader research and clinical community in the measurement
of cognitive change and accelerate discovery in biomedical research focused on understanding, and ultimately
improving, cognitive and brain health across the adult lifespan. Innovations in various avenues to enhance the
quality of researcher engagement and support for uptake and further developments of the M2C2 test
infrastructure will provide a dynamic cycle of development and deployment of these tools.

Public health relevance
Project Narrative Identification of modifiable risk factors prior to the development of neurological conditions in old age represents a critical challenge for developing effective treatment and preventive measures, controlling health care costs, and ultimately improving the quality of life for seniors and their families. This requires methods to detect subtle cognitive changes years prior to the onset of discernable symptoms. The proposed research will significantly advance these efforts by developing innovative ambulatory methods that rely on mobile and sensor technology to measure the cognitive and behavioral function of people in their everyday life. These methods could provide more cost-effective, accurate, sensitive and `ecologically valid' measurements of early signs of cognitive impairment than are currently available through standard laboratory and clinical practices. By improving our ability to measure cognitive function in daily life, this work will set the stage for the next generation of early intervention and prevention studies to slow or prevent cognitive decline.